The oral environment in food allergy development (ONEIDA)

PROJECT SUMMARY
Food allergy, an incurable condition affecting ~10% of the US population, is a departure from immune
homeostasis where aberrant antibody response, microbial dysbiosis, and local and systemic symptoms are
well-reported. With exposure to culprit foods, individuals with food allergy experience symptoms including oral
swelling, hives, vomiting, and anaphylaxis. The oral mucosa is the first interface between ingested food
antigens and the immune system. Our studies have revealed differences in food-specific antibody levels in
saliva between food allergic children and those who are only food sensitized. We have shown that allergen-
specific antibody profiles in saliva can predict food allergy threshold, severity, and organ-specific symptoms.
We have also found that the saliva microbiome and metabolome differ in children with and without food allergy.
Building on this work, we aim to study the origins of food allergy and propose to characterize the early-life
trajectory of the oral environment as food allergy arises. To date, there has been no study of the oral
environment as children acquire food allergy. Our central hypothesis is that the development of food
allergy is associated with distinct trajectories during the first three years of life in oral mucosal
immunology, oral microbial communities and metabolites, and their cross-talk with systemic factors.
We will leverage longitudinal samples and existing data from the NIH/NIAID Systems Biology of Early Atopy
(SunBEAm) study, a multi-center birth cohort of 2,500 children from across the US who have undergone
extensive longitudinal phenotyping, including doctor-supervised food challenges for food allergy assessment.
We have been leading and working on SunBEAm since it began. To address our first hypothesis that the
inception of food allergy is associated with a distinct oral mucosal immunologic trajectory, we will
characterize the development of allergen-specific antibodies and cytokine milieu in saliva during the first 3
years of life and identify saliva antibody and cytokine predictors of food allergy inception (Aim 1). To address
our second hypothesis that children who attain food allergy host different oral microbial communities and
metabolites, we will profile the saliva microbiome and metabolome during the first 3 years of life and chart
microbial and metabolite dynamics associated with food allergy acquisition (Aim 2). Our third hypothesis is that
directional cross-talk between the oral and systemic environments is associated with food allergy
development. We will build temporal networks and employ causal methods to integrate the multi-dimensional
oral data generated by this study with multi-omic systemic data that we have in hand for the same participants
to identify directional relationships between the oral and systemic environments over time and their causal
impact on food allergy onset (Aim 3). This study will generate unprecedented findings on the immunologic,
microbial, and metabolomic trajectories of the early-life oral environment and their relationship with food allergy
development. Findings could inform food allergy prevention and biomarkers using non-invasive saliva samples.

Public health relevance
PROJECT NARRATIVE Food allergy is an incurable and increasingly common condition affecting ~10% of the US population where food allergic individuals can experience mouth/throat swelling, hives, vomiting, and anaphylaxis when eating foods to which they are allergic. The oral environment is the first interface between ingested foods and the immune system, and this project will study a multi-center birth cohort of 2,500 children recruited from 12 US sites to address the hypothesis that the origins of food allergy are linked to distinct paths during the first three years of life in oral immune development, oral microbial communities and metabolites, and how they interact with broader systems in the human body. Findings from this study could inform approaches to prevent food allergy and ways to detect food allergy risk factors using non-invasive saliva samples.